CORE A: ADMINISTRATIVE CORE

SUMMARY
The major objectives of the Administrative Core of the Cooperative Center on Human Immunology at the Emory
Vaccine Center (CCHI-EVC) are to institute streamlined processes facilitating productive interactions among
the investigators of the renewal grant application entitled “Vaccine and Infection Induced Immunity in the
Young and Aged”. To achieve these objectives and to ensure a seamless operation of the Core, we will
establish an Administrative Core Committee (ACC) for carrying out the following activities/functions at the CCHI-
EVC:
1) Provide the infrastructure for the overall management and co-ordination at the Center. 2)
Facilitate and promote communication and interaction among the PIs/investigators (Research
Projects 1-3 and Cores B and C) by conducting regular progress Zoom/face-to-face meetings,
annual meetings, as well as seminars/symposia on human immunology. 3) Provide
fiscal/scientific/core oversight, review and consolidate yearly progress reports sent to the NIH. 4)
Protect intellectual property rights of CCHI-EVC investigators and to execute material transfer
agreements. 5) Resolve all or any potential conflicts that might arise within and outside of CCHI-
EVC by implementing recommendations of the Conflicts Resolution Group. 6) Devise a plan for
data management/sharing among investigators in and out of CCHI-EVC and to deposit data to
ImmPort, as per the mandates of NIH policy
Thus, the Administrative Core is organized to foster a high degree of synergy and productive interaction among
investigators for achieving success in the overall objectives of CCHI-EVC.

Public health relevance
The Administrative Core is designed to play a central role in the coordination of both scientific and administrative activities among the various institutions represented at the Emory University CCHI and to promote synergistic interactions.